The Bioimaging Core

SUMMARY
The Bioimaging Core (BIC) in the Columbia University Digestive and Liver Disease Research Center (CU-
DLDRC) will make essential contributions for the understanding and treatment of digestive diseases. State-of-
the-art imaging can resolve the complex interactions between cells, organs, metabolites and microbiota that
regulate digestive health and disease. However, the cost and expertise of maintaining and operating complex
imaging platforms are beyond the financial and technical means of most individual laboratories. The overall goal
of the BIC is to provide CU-DLDRC members with state-of-the-art imaging platforms to study mechanisms of
digestive health and disease in small animals and human biospecimens in vitro and in vivo, providing resolutions
ranging from nanometers to centimeters. The BIC is organized into two units with high-end digestive-focused
imaging capabilities backed by expert technical assistance, each led by a highly qualified director with
longstanding experience in imaging and core administration. The Microscopy Unit, overseen by BIC Co-Director
Liza Pon, provides access to a sophisticated suite of microscopes, including single, multiphoton and spinning
disk confocal, super-resolution and total internal reflection fluorescence microscopy, which allow rapid and high-
resolution imaging of living or fixed digestive tissue specimens. The Small Animal Imaging Unit, overseen by BIC
director Ken Olive, provides access to high-end magnetic resonance imaging, ultrasound, X-ray computed
tomography, and optical imaging instruments for imaging of digestive organs and their functions in small animals.
In addition, the BIC will develop new digestive-focused imaging modalities, including (i) imaging mass
spectrometry with CU-DLDRC member Brent Stockwell for high resolution imaging of metabolites in digestive
tissue; and (ii) SCAPE imaging, a novel meso-scale optical platform based on endogenous tissue fluorescence,
engineered by CU-DLDRC member Elizabeth Hillman. The Small Animal Imaging unit will also develop novel
applications specific for the assessment of gastrointestinal motility, fibrosis, inflammation, tracking of engineered
microbes, and in vivo measurement of metabolites. The BIC will contribute to the overall mission of the CU-
DLDRC through the following interrelated Aims: To analyze cellular structures and processes that regulate
epithelial health in digestive tissues via microscopy (Aim 1); to provide in vivo small animal imaging technologies
for the study of digestive physiology and disease (Aim 2); and to provide hands-on training and education in
advanced digestive imaging applications (Aim 3). BIC will be a highly utilized resource with 43 out of the 49 CU-
DLDRC members (88%) planning to use its services. Via multicore workflows, BIC will closely link to the other
CU-DLDRC biomedical cores, thus providing CU-DLDRC members with easy access to imaging clinical
biospecimens and organoids, or combining their imaging with advanced bioinformatics analyses. In sum, BIC
will benefit the research of basic and clinical CU-DLDRC members and provide significant value added.